Genetic Origins of Adverse Outcomes in African Americans with Lymphoma

ABSTRACT
Diffuse large B cell lymphoma (DLBCL) is the most common form of blood cancer and is characterized by a
striking degree of genetic heterogeneity. It has been known for some time that African American patients have
poorer outcomes than Caucasian patients. After correcting for potential differences in socioeconomics and
access to care, our data indicate that the poorer outcomes in African Americans arise primarily from distinct
genetics of their tumors. The underlying genetic causes of these poorer outcomes have not been studied
systematically. Here, we propose to investigate tumor and germline genetics of African Americans to
comprehensively understand the genetic basis of their poorer outcomes. Preliminary genomic analysis of
African American DLBCL patients has revealed more frequent mutations in histone methyltransferase genes
and other genes. In this proposal, we seek to comprehensively define the genetic origins of poor outcomes in
African Americans with DLBCL and perform functional characterization of selected genomic alterations.

Public health relevance
PROJECT NARRATIVE African Americans with DLBCL exhibit worse outcomes than Caucasians, even after correcting for potential differences in socioeconomics and access to care. We propose to comprehensively examine the distinct genetics of DLBCL in African Americans. We will also study the mechanisms of genomic alterations that are more frequently found in African American patients.